Modeling Enhancer Hijacking in Cancer via Genome Engineering and Single-Cell Sequencing

PROJECT SUMMARY
Structural variants (SVs) are a major contributing factor to human cancer. Non-coding structural variants were
found to cause rearrangements of chromosomes, resulting in the rewiring of Enhancer-Promoter communication.
Despite our knowledge of the function of enhancer-promoter re-wiring in gene regulation, recent studies in
human cancer suggested that structural variants that altered gene expression nearby are rare. What
distinguishes structural variants that alter nearby gene expression from those that do not remains unclear.
Therefore, this gap in understanding gene regulation in the rearranged genomes prevents us from modeling
gene regulation near structural variants. To address this, recent work from Dr. Xu engineered translocations near
MYC and showed that the activation of MYC after rearrangements requires both adjacent enhancer activity and
strong contact between enhancer and promoter. This finding suggests that the Activity-By-Contact (ABC) model
can predict MYC activation after translocation. However, the ABC model is still not precise in predicting the
accurate expression level. Further, it is unclear how well these models generalize to other genes in the genome,
and whether additional chromatin regulatory machinery can improve the predictions. This proposal aims to
investigate the role of trans-acting factors and cis-element sequences in oncogene activation in rearranged
human genomes. The central hypothesis is that quantitative oncogene expression modeling should include the
variable binding of trans-acting factors, as well as the promoter sequences. Dr. Xu will employ CRISPR/Cas9
genome engineering to introduce different chromosomal translocations near the oncogene, whose expression
will be modeled from the single-cell multi-omic sequencing data (Aim 1). Subsequently, Dr. Xu will systematically
identify TFs/co-activators specific to certain oncogenes or structural variants by performing CRISPR KO screens,
followed by molecular mechanism study using a dTAG-based degron and genomic profiling (Aim 2). Finally, Dr.
Xu will characterize promoter sequence features that render genes susceptible to enhancer-hijacking, by
developing a novel method that interferes with sequences and simultaneously measures the genome
conformation in single-cell (Aim 3). Overall, the results from this proposal will reveal new regulatory roles of TFs
and other regulators in gene expression in the context of rearrangement.
Dr. Xu’s career goal is to lead an independent research group devoted to applying novel computational and
experimental approaches to investigate gene regulation in disease and evolution. In the year prior to K22
activation, he will continue to receive computational and experimental training from his postdoctoral mentor and
consultants at the Salk Institute for Biological Studies and UT Southwestern Medical Center. The rigorous
mentored support and results obtained will facilitate Dr. Xu’s transition to independence as an investigator in the
K22 phase and lay the foundation for his future career.

Public health relevance
PROJECT NARRATIVE Gene activation depends on the communication between the enhancer and the gene promoter. Transcription factors are known to mediate and regulate this process through binding to the genomic DNA. This proposal aims to investigate the role of transcription factors and genomic sequences in oncogene regulation, and further model oncogene activation in human cancer.